Low - Field MR Fingerprinting for Myocardial Tissue Characterization in Patients with Cardiac Implantable Electronic Devices

PROJECT ABSTRACT/SUMMARY
Over two million Americans have a cardiac implantable electronic device (CIED) to manage arrhythmias, often
secondary to cardiomyopathies, and prevent sudden cardiac death. Magnetic Resonance Imaging (MRI) is a
powerful tool for non-invasive detection of myocardial tissue abnormalities—including inflammation, edema, and
fibrosis—using late gadolinium enhancement (LGE) imaging and quantitative T1, T2, and extracellular volume
fraction (ECV) mapping. However, MRI remains widely underutilized in patients with CIEDs, as metallic
components in these devices distort the magnetic field and create off-resonance artifacts that severely degrade
image quality. Although 16% of patients with CIEDs will develop a clinical indication for cardiac MRI at some
point, they are 40% less likely to undergo an MRI exam than non-CIED patients, leaving clinicians to rely on
alternative modalities that lack detailed tissue characterization capabilities. This project aims to address this
unmet need by developing MRI technology for robust myocardial tissue characterization specifically tailored for
CIED patients, providing quantitative tissue property maps (T1, T2, proton density, and ECV) and multi-contrast
LGE images from a single imaging platform. Our solution is based on Magnetic Resonance Fingerprinting (MRF),
an innovative framework that measures temporal changes in magnetization (“fingerprints”) to achieve rapid
multiparametric mapping. We propose a novel cardiac MRF technique that is separately optimized for
conventional 1.5T scanners, given that most CIED patients are currently imaged at this field strength, as well as
emerging low-field 0.55T scanners, which offer inherent advantages for imaging near metallic implants, such as
reduced off-resonance artifacts. In Aim 1, we will develop the proposed technique in parallel for 1.5T and 0.55T
by integrating robust data collection strategies, such as center-out radial sampling and wideband excitation
pulses, with a physics-informed deep learning reconstruction that further suppresses off-resonance artifacts and
residual motion. We will evaluate accuracy, precision, and repeatability in phantoms and healthy subjects with
an externally positioned CIED scanned at both field strengths compared to conventional cardiac mapping
methods. In Aim 2, we will assess MRF for native and post-contrast mapping in cardiomyopathy patients with
CIEDs at 0.55T and 1.5T and validate methods for detecting myocardial fibrosis, given its prognostic importance
in many conditions. To this end, we will generate synthetic multi-contrast (bright- and dark-blood) LGE images
from post-contrast MRF maps, which we expect to simplify the exam and enhance detection of fibrosis compared
to conventional bright-blood wideband LGE scans. Furthermore, we will develop a clustering algorithm that
directly analyzes tissue property maps to identify fibrosis, serving as a semi-automated and operator-
independent alternative to LGE. This project has the potential to have a significant and immediate impact on
public health by expanding access to advanced MRI techniques for myocardial tissue characterization in CIED
patients, who are at high risk of adverse cardiovascular events yet are underserved by current MRI technology.

Public health relevance
PROJECT NARRATIVE Although Magnetic Resonance Imaging (MRI) offers unique insights into myocardial tissue abnormalities, such as inflammation, edema, and fibrosis, its use is limited in patients with cardiac implantable electronic devices (CIEDs) due to metal-induced artifacts that severely degrade image quality. This project will develop a Magnetic Resonance Fingerprinting (MRF) technique designed specifically for CIED patients, providing quantitative tissue property maps and multi-contrast late gadolinium enhancement (LGE) images in a rapid “all-in-one” framework, deployable on both conventional 1.5T and emerging low-field 0.55T scanners that have inherent advantages for imaging near metallic implants. The proposed research has the potential for significant and immediate clinical impact by addressing a pressing unmet need for robust myocardial tissue characterization in CIED patients, a population at high risk for adverse cardiovascular events that is underserved by current MRI technology.